Core Grant for Vision Research - Core 1

CORE 1: OCULAR OMICS AND QUANTITATIVE MOLECULAR BIOLOGY
ABSTRACT
The goal of Core 1 is to provide the following services to users with qualifying grants and other vision
researchers. The quantitative molecular biology services include providing consultation for and
access to quantitative PCR, access to plate readers for quantitation of antibodies, cytokines, and
other analytes, access to spectrophotometers and a bionalazyer for RNA, DNA and protein samples,
a laser microdissection system to obtain material from tissue sections for transcriptomics,
metabolomics, or proteomics analysis, allelic characterization of normal and genetically modified
mice, nucleic acid probe design, in situ hybridization, quantitative reporter gene analysis. This core
will also facilitate use of campus resources such as the Biotechnology Center (NextGen Sequencing,
RNAseq, data handling and analysis, proteomics, etc.) and the Flow Cytometry Facility.

Public health relevance
CORE 1: OCULAR OMICS AND QUANTITATIVE MOLECULAR BIOLOGY NARRATIVE The goal of Core 1 is to provide the following services to users with qualifying grants and other vision researchers. The quantitative molecular biology services include providing consultation for and access to quantitative PCR, access to plate readers for quantitation of antibodies, cytokines, and other analytes, access to spectrophotometers and a bionalazyer for RNA, DNA and protein samples, a laser microdissection system to obtain material from tissue sections for transcriptomics, metabolomics, or proteomics analysis, allelic characterization of normal and genetically modified mice, nucleic acid probe design, in situ hybridization, quantitative reporter gene analysis. This core will also facilitate use of campus resources such as the Biotechnology Center (NextGen Sequencing, RNAseq, data handling and analysis, proteomics, etc.) and the Flow Cytometry Facility.